Using novel behavioral economic measures to characterize dual marijuana and tobacco use in young adults

PROJECT SUMMARY
Young adulthood is a crucial period for understanding the development of substance use disorders, which can
lead to the development of cancer later in life. Two substances in particular, marijuana and tobacco, are of
critical importance due to their prevalence and potential impact on this vulnerable age group. Marijuana use
has reached critically high rates in young adults, and the majority of young adults endorsing marijuana use
also smoke tobacco. Dual use of both substances is associated with a greater risk of health and behavioral
problems later in life. However, behavioral mechanisms underlying marijuana and tobacco dual use are not
well characterized. Novel methods and experimental data are urgently needed to better model and
understand behavioral mechanisms underlying young adult dual use of marijuana and tobacco in
order to reduce cancer risk across the lifespan. We propose to characterize young adults who smoke
of marijuana and cigarettes (YASMCs) using rigorous laboratory-based behavioral economic
measures: a novel cross-price elasticity of demand (CPED) task we have developed and an innovative
extension of cue-induced demand to assess cross-cue reactivity. CPED can tell us how demand for one
substance may shift as the price and availability of another substance changes in a model that approximates
real-world tradeoffs. If these substances act as substitutes for an individual, then as the value of one
decreases, demand for the other increases. In this case, cessation efforts aimed at one substance may lead to
increases in use of the alternative substance. If they are complements, increasing access and exposure to one
substance may drive a concomitant increase in demand for the alternative substance. Cross-cue induced
demand can tell us the extent to which environmental cues (e.g., smoke, drug paraphernalia) can elicit
elevated demand for the alternative substance in the moment. Thus, increased exposure to drug-specific cues
could lead to unintended harms such as increased craving for both substances. Participants (N = 120) will be
young adults (age 18-25) endorsing current tobacco and marijuana use and will complete 4 experimental
sessions: one in which they will complete baseline assessments and the CPED task, 3 cross-cue reactivity
sessions (cigarette cues, marijuana joint cue, and “blunt’ or mixed tobacco and marijuana cue; each precede
by neutral cues in a single session), and a qualitative exit interview about modes of cannabis and tobacco use.
Outcome measures will include: 1) degree of substitutability on the CPED, 2) change in demand for each
alternative substance in the presence of target-substance cues, and 3) relationships between these outcomes
and other measures of dual use. This proposal addresses NCI’s priority areas of: “Behavioral research in
cancer prevention and control: Development and testing of interventions addressing risk behaviors
such as: tobacco use” and will contribute to TCRB’s research priority area of “Etiology, predictors,
correlates, and determinants of tobacco use, nicotine dependence, and cessation”.

Public health relevance
PROJECT NARRATIVE Dual use of cigarettes and marijuana in young adulthood (age 18-25) is both prevalent and associated with a greater risk of problems later in life. However, the mechanisms of dual use are not well-understood, making identification of the highest-risk young adults difficult and effective intervention development challenging. This proposal will use a behavioral economic laboratory-based protocol to generate experimental data that will help characterize and identify high-risk subpopulations of young adults endorsing dual use of marijuana and tobacco, allowing for the study of etiology, prevention, and treatment of dual use in young adults.